Molecular Biology of the Vasculature

The proposed meeting will be an integrated program on pancreatic islet developmental biology and pancreatic islet transplantation. Both areas are on the forefront of several scientific disciplines (developmental biology, stem cells, transcription factors, transplantation, cell biology, gene regulation, and diabetes) and are the subject of intense scientific investigation. Islet transplantation, an emerging therapy for diabetes, is severely hampered by the lack of a sufficient number of islets for transplantation. A major goal of work to understand pancreatic islet development is the generation of new islets from stem cells (adult or embryonic). Challenges relevant to both fields are an incomplete understanding of the mechanisms controlling normal islet development and function and lack of information about islet cell differentiation, survival, and function after transplantation. The proposed program will focus on these scientific challenges by reviewing progress in these rapidly expanding fields and discussing strategies to overcome these obstacles. The proposed program will fill a unique need in that prior scientific meetings have focused on one topic or the other and have not brought together the leaders in both fields. The planning committee, consisting of two investigators with expertise in islet transplantation and two with expertise in pancreatic islet development, has structured the program to foster interaction between scientists and thus accelerate progress in these scientific areas.